Project 1: New epigenetic therapy targets

Abstract
Epigenetic therapy aims to reprogram gene expression in cancer cells to achieve a therapeutic effect. To date,
DNMT inhibition is the most effective form of epigenetic therapy in myeloid leukemias. We have developed and
validated a live cell assay to screen for drugs that achieve the same degree of epigenetic reprogramming as
DNMT inhibition. Using this screen, we discovered a new class of epigenetic drugs that activate silenced
expression through inhibition of CDK9. CDK9 is a transcriptional regulator previously linked to gene activation
through the pTEFb complex that phosphorylates RNAPII and promotes transcriptional elongation. Our new data
now place CDK9 at the heart of a node that regulates both gene silencing and activation in proliferating cells. As
such, targeting CDK9 has pleotropic effects on gene expression that appear ideal from an anti-tumor
perspective: One observes simultaneous gene activation (of tumor suppressors), repression (of oncogenes),
and induction of an interferon immune signature, which may be immune-sensitizing. Known CDK9 inhibitors
(flavopiridol, SNS-032) have activity in leukemias but are marred by serious chemotherapy-like toxicities.
Examining published data, we find that doses of these drugs in use clinically are at least an order of magnitude
higher than what is needed to inhibit CDK9, and we speculate that the toxicity observed is typical of cross-target
inhibition of other CDKs (e.g. CDK1/2). Thus, we hypothesize that low doses of CDK9-selective drugs may
preserve activity through epigenetic effects of CDK9 inhibition, while reducing toxicity by avoiding other
CDKs. In this grant, we will elucidate mechanisms of epigenetic effects of CDK9, determine the downstream
effects of CDK9 inhibition on cellular function and immune responses, and conduct a clinical trial of a new CDK9-
selective drug in myeloid leukemias. Successful completion of these aims will introduce a new form of epigenetic
therapy in the treatment of leukemias.

Public health relevance
Project Narrative Epigenetic therapy seeks to treat cancer using drugs that change gene expression by targeting proteins that regulate epigenetics – a set of chemical modifications that are essential to cellular identity and that are reshuffled in cancer cells. The aim is this therapy is primarily “reeducation” of the cancer cell rather than direct killing and therefore could be less toxic than traditional chemotherapies. In this grant, we will follow-up on earlier successes in this field by testing a new way to achieve epigenetic therapy through inhibition of a protein called CDK9.